MUST Data Science Research Hub (MUDSReH)

Overall Research Plan Project Summary. Significance. Data science hold great promise for sub-Saharan Africa, yet research capacity and appropriate training are limited. Medical images are particularly exciting for data science in this setting given their ability to facilitate care delivery across healthcare cadres. Efforts to translate the knowledge gained through data science into improved clinical care can be fostered through implementation science. Strategic multi-disciplinary, multi-institutional partnerships will be key for the development and ultimate impact of data science for African-based solutions. Innovation. This proposal is innovative in 1) its use of data science with medical images for advancing clinical care, and 2) integration of data science with implementation science to promote clinical impact. Approach. The Mbarara University Data Science Research Hub (MUDSReH) in Uganda will use multiple technologies to improve the capture of medical images and employ key data science methods, such as machine learning and artificial intelligence, to expand their utilization in sub-Saharan Africa. Clinical impact will be strengthened through implementation science methods. Formal training will be available for both data science and implementation science, and ongoing expansion of efforts will be promoted through regional summits and collaboration. The two initial research projects—optimized posterior fundus imaging to diagnose posterior segment eye disease and mobile- phone based cervical images to detect cancer—will involve partnerships with the College of Ophthalmologists of Eastern, Central and Southern Africa in Kenya and the Kwame Nkrumah University of Science and Technology in Ghana, respectively. Massachusetts Institute of Technology will provide technical support for data management and analysis, and Massachusetts General Hospital will support the use of implementation science and other relevant content areas for individual research projects. Each project will work with local Ministries of Health, community-based organizations, and/or technology partners to advance the mission of harnessing medical images for improved clinical outcomes and impact. Our specific aims are as follows: 1. To integrate all partnering academic institutions, technology companies, and non-governmental organizations to advance data science for medical imaging. All partners will contribute to a common infrastructure for data processing and analysis. We will establish both the administrative and technical mechanisms for data exchange, accounting for necessary data security and quality assurance and control. We will further create pathways for facile expansion to include additional research projects involving medical imaging (e.g., in radiology and dermatology) at multiple African institutions. 2. To integrate implementation science with data science to advance clinical impact. All research projects in the MUDSReH will include implementation science methodologies to ensure the developed technology reaches the end user in practical ways that meet local needs and priorities.

Public health relevance
Overall Research Plan Project Narrative Medical images offer great potential for supporting clinical diagnosis and care management; however, their utility for African researchers and clinicians are limited by the number of images available, insufficient linkage to relevant clinical data, limited data from African populations for proper image interpretation, and poor implementation in clinical practice. The Mbarara University Data Science Research Hub is designed to overcome these barriers through robust Data Management and Analysis and Administrative Cores, initially supporting projects in posterior segment eye disease and cervical cancer with plans for expansion to new projects and sites, as well as training in data science and implementation science.